INCREASING PREVENTIVE ACTION FOR CHILDHOOD INJURY

The major purpose of the Increasing Preventive Actions for Childhood Injury study is to develop and test an intervention to reduce parental unsafe practices for childhood injuries in the home. A multicomponent preventive intervention for pediatric health care providers and parents will be developed and evaluated.